Methods for Adaptive Randomized Trials in Infectious Disease Research

Project Summary/Abstract
In building a proactive response to future epidemics and pandemics, interim analyses can help investigators
evaluate countermeasures efﬁciently even under unpredictable outbreak conditions. At a pre-planned interim
analysis, a clinical trial can save time and resources by stopping early when overwhelming evidence exists in
favor of or against an experimental intervention. When investigators can no longer collect further data for the
foreseeable future due to waning transmission, an unplanned interim analysis can help determine whether a trial
should stop early given the existing observations or pause until more infections emerge in a subsequent outbreak.
At the same time, study power may be lost if investigators conduct interim analyses without modifying the trial to
account for the early stopping opportunities. Statistical challenges also arise when conducting interim analyses in
cluster randomized trials (CRTs), which are well-suited for infectious disease research because of their desirable
statistical and logistical features. This proposal seeks to address these methodological gaps by developing meth-
ods for (1) calculating the sample size of a CRT with pre-planned interim analyses and (2) maintaining statistical
validity when conducting unplanned interim analyses, which will help bolster the public health community's ability
to mount a timely response to epidemics and pandemics.
Traditional interim analysis methods depend on the independence of additional data between analyses, which
does not necessarily hold for CRTs because outcomes are correlated and recruitment can occur at both the
cluster and individual levels. Aim 1 assesses when this independent increments property holds and proposes a
Fisher information-based approach to determine the maximum and expected number of clusters or cluster size for
a CRT with pre-planned interim analyses and continuous, binary, or event rate outcomes. Motivated by the need
to extend a trial across multiple outbreaks to accommodate the unpredictable nature of an epidemic or pandemic,
Aim 2 develops methods for adaptively redesigning an ongoing trial to incorporate unplanned interim analyses in
randomized trials with binary or time-to-event outcomes while maintaining a desired Type I error rate and power.
The proposed research will be conducted at the Harvard T.H. Chan School of Public Health and Harvard Med-
ical School, two highly collaborative, innovative, and impactful research environments. Working with professors
from the Department of Biostatistics, Department of Population Medicine, and Center for Biostatistics in AIDS
Research, the trainee will learn how to conduct research that tackles pressing problems in public health and
statistics. During this fellowship, the trainee will cultivate his statistical and epidemiological knowledge through
additional coursework; develop his written and oral communication skills by publishing manuscripts in high-impact
peer-reviewed journals and presenting at workshops and conferences; and grow his teaching skills by working as
a teaching fellow and instructor to high school students interested in biostatistics.

Public health relevance
Project Narrative Interim analyses, whether planned or unplanned, can help expedite the evaluation and deployment of counter- measures during clinical trials conducted in infectious disease outbreaks. To effectively carry out such analyses, investigators must account for the unique design features that arise in infectious disease research, including cluster randomization and the dynamic nature of disease transmission. This proposal addresses these method- ological challenges, providing tools for implementing ﬂexible trials that help researchers better understand, treat, and ultimately prevent infectious diseases while ensuring statistical validity and efﬁciency.